Latinx Hazardous Drinkers with Clinical Anxiety: Effectiveness Trial of a Personalized Normative Feedback Intervention

Project Summary/Abstract
Despite being one of the largest and fastest-growing demographics in the United States (US), Latinx persons
experience striking health disparities, particularly in terms of hazardous drinking and co-occurring clinical
anxiety. No interventions to date have targeted hazardous drinking in the context of clinical anxiety among
Latinx persons. The current R01 proposal builds upon our past work by developing a brief, single-session,
computer-based, personalized feedback intervention (PFI) designed to enhance knowledge regarding adverse
anxiety-alcohol interrelations, increase motivation and intention to reduce hazardous drinking, and reduce
positive attitudes and intentions regarding the use of alcohol for anxiety. Specifically, we propose to develop a
low-cost, highly disseminatable, integrated PFI for Latinx hazardous drinkers with clinical anxiety (AA-PFI 1.0)
that will be implemented and tested for effectiveness in community-based health clinics. Our approach will
follow a staged model consistent with National Institutes of Health (NIH) guidelines for developing and
standardizing behavioral interventions. Phase IA activities will involve collecting qualitative and quantitative
feedback from three iterative focus groups (N = 21) to refine intervention content and evaluate treatment
acceptability and feasibility. Phase IB activities will include a rigorous randomized clinical trial designed to
compare the effectiveness of AA-PFI 2.0 to a control PFI (C-PFI) among a sample of 250 Latinx hazardous
drinkers with clinical anxiety who receive care within community-based health clinics. This study represents an
important and pivotal step in the larger landscape of translating basic research to more efficacious strategies
for reducing hazardous drinking in underserved populations with biobehavioral comorbidities. The proposed
research project supports the 2017-2021 strategic plan of the National Institute on Alcohol Abuse and
Alcoholism (NIAAA) by advancing research in two of the key areas. First, the current proposal has the end goal
of improving strategies to prevent alcohol misuse, alcohol use disorder, and alcohol-related consequences
among an ‘at-risk’ population for these conditions (goal 3). Second, it enhances the public health impact of
NIAAA-supported research by focusing on one of the fastest-growing and largest demographics in the US who
demonstrate disparities in hazardous drinking (goal 5). The current application aligns with the goals of RFA-
AA-21-001 by proposing to examine the effectiveness of a low cost, highly disseminatable, personalized,
culturally adapted PFI for Latinx hazardous drinkers with clinical anxiety within community-based health clinics.
Given the collective public health impact of concurrent anxiety and alcohol use, we believe the proposed study
will yield findings that enhance scientific knowledge, advance our understanding of mechanisms in anxiety-
alcohol use relations, and inform the development of novel treatments for hazardous drinkers with clinical
anxiety that are adaptable and easily implemented across a variety of healthcare settings.

Public health relevance
Project Narrative There is a public health need to develop novel, culturally adapted interventions to reduce alcohol consumption among Latinx hazardous drinkers with comorbid clinical anxiety. The proposed R01 study will draw upon National Institutes of Health (NIH) treatment development guidelines (Stage 1) to translate and innovate past work to address a major public health priority. Specifically, we propose to develop (Phase IA) and test (Phase IB) the effectiveness of a brief, integrated, single-session, computer-based, culturally adapted personalized feedback intervention (PFI) designed to enhance knowledge regarding adverse anxiety-alcohol interrelations, increase motivation and intention to reduce hazardous drinking, and reduce positive attitudes and intention regarding anxiety-related alcohol use among Latinx hazardous drinkers with anxiety within community-based health clinics.